Lysophosphatidic Acid and Cardiovascular Disease Risk

Veterans have a higher incidence of cardiovascular disease than the general population. Valvular diseases
including Calcific Aortic Valve Disease (CAVD) are a particular concern for the aging Veteran Population. At
present, there is no medical therapy to delay or reverse CAVD, and the only treatment is valve replacement for
severe aortic valve stenosis. CAVD involves remodeling of the heart valve tissue as a consequence of
endothelial injury, immune cell infiltration and myofibroblastic / osteogenic differentiation of cells that can
ultimately result in valve leaflet thickening and profound calcification. The fibrosis and calcification stiffen the
leaflets and can result in leaflet fusion that reduces valve opening and causes valve stenosis. Understanding
the molecular mechanisms that drive these changes might lead to the development of much needed therapies
for CAVD. In the past funding period we made mouse models to study the roles of a bioactive lipid,
lysophosphatidic acid (LPA) in cardiovascular and metabolic disease processes. In the course of these studies
we found that mice deficient in the enzyme autotaxin (ATX) that generates LPA were protected from valve
calcification and thickening in a commonly used experimental model. We also observed that mice lacking the
enzyme lipid phosphate phosphatase 3 (LPP3) that can inactivate LPA exhibited greater valve calcification in
this model. These findings are likely translatable to humans because LPP3 levels are decreased during
development of human CAVD while ATX accumulates in the valve tissue and ATX binds to lipoprotein (a)
particles which are themselves associated with CAVD risk. Valvular Interstitial Cells (VICs) are resident cells of
the heart valve tissue that are normally responsible for maintaining the integrity of the heart valves. Pathological
differentiation of these cells to myofibroblastic and osteogenic phenotypes is central to the development of
CAVD. Consistent with literature reports, our preliminary data shows that mouse and human VICs express LPA
selective cell surface receptors. Differentiation of these cells to an osteogenic phenotype and subsequent
calcification can be readily observed in culture medium containing serum which is a rich source of LPA.
Pharmacological antagonism of LPA receptors blocks osteogenic differentiation and calcification of these cells
in culture. In the past funding period we characterized transcriptional circuits that regulate LPP3 expression to
understand why expression is increased in inflammation and decreased by heritable variants that associate with
increased coronary artery disease risk. These studies provide reagents and a framework for understanding why
LPP3 expression is decreased in CAVD. Here we propose to test the broad hypothesis that LPA signaling
promotes CAVD. We will test this hypothesis by using mouse models with cell and tissue type selective
inactivation of LPA receptors, LPP3 and ATX to identify the cell and tissue types involved the permissive effect
of LPA on CAVD with a particular interest in the possibility that secreted ATX and cell surface LPP3 could have
non cell autonomous effects on this process. As an orthogonal approach, we will use well characterized
experimental therapeutics (ATX inhibitors and LPA receptor antagonists) to validate results from these gene
knockout models and evaluate their potential for pharmacological intervention in CAVD. Studies in mouse
models will be augmented by experiments using cultured mouse and human VICs where again cells with genetic
deficiencies or treatment with small molecule therapeutics can be used to define the role of LPA signaling in
osteogenic differentiation and calcification. We will also examine how LPP3 expression is regulated during these
processes and test specific hypotheses about why LPP3 expression is decreased during development of CAVD.
This research will provide important new information about a pharmacologically tractable lipid signaling pathway
that appears to be central to the development of CAVD. This information could lead to new approaches for non-
surgical management of CAVD in Veterans.

Public health relevance
Veterans, particularly the elderly, have a higher incidence of heart diseases than the general population including hardening of the valves of the heart which is a debilitating condition with no effective non-surgical treatment options. This disease involves the aortic valves becoming “bone like” and rigid which prevents the valve from opening properly and stresses the heart as it tries to pump blood out the valve. This research will study the processes underlying these changes in the heart valve and evaluate the potential efficacy of drugs as inhibitors of hardening of the valves. These drugs might have benefit to protect Veterans from developing this condition or potentially reverse the condition in Veterans with established aortic valve disease.